Transcriptional Control of Cellular Survival and Proliferation in KSHV-transformed B Cells

Project Summary/Abstract This page intentionally left blank in order to avoid an error.

Public health relevance
Project Narrative This page intentionally left blank in order to avoid an error.